Developmental Funds

PROJECT SUMMARY/ABSTRACT
CCSG Developmental Funds are a vital mechanism for furthering the strategic mission and vision of the
Markey Cancer Center (MCC) through pilot funding to MCC members and support of emerging Shared
Resource Facilities. During the current funding period, Developmental Funds helped support 17 basic, clinical,
population and translational cancer research pilot projects from MCC’s Molecular and Cellular Oncology,
Cancer Prevention and Control, and Translational Oncology Research Programs, stimulating a high return on
investment of $15.16 per CCSG dollar. These projects have fostered five new extramurally funded grants and
have opened clinical trials that accrued 241 new participants. In close alignment with MCC’s scientific direction,
14 of the 17 projects are on topics that correspond to the center’s FY19-23 Research Priorities for the current
funding period, including those involving clinical and health disparity issues within the MCC catchment area.
Outside of the routine CCSG pilot award process, MCC also elected to use Developmental Funds to support
two interdisciplinary teams of researchers who ultimately successfully applied for a CCSG Supplement
designed to foster the development of multiproject research programs. Developmental Funds were also
invested in two developing Shared Resource Facilities (Oncogenomics and Patient-Oriented and Population
Sciences), which have supported research projects from all three MCC programs, and after careful annual
evaluation, have been approved by the MCC Director’s Council as fully functioning resources presented as
such in this CCSG application. Leveraged with philanthropic investment and institutional support,
Developmental Funds will also be strategically allocated during the upcoming funding period to address two
Specific Aims: 1) Cultivate innovative and collaborative science through the use of pilot grants in areas that
align with MCC’s FY24-28 Strategic Plan and Research Priorities and reflect the scientific aims of MCC’s three
Research Programs; and 2) Foster deeper collaboration across the UK campus through strategic partnerships
to fund innovative pilot awards and ensuring the continuation of community input through the CCSG pilot
review process. To achieve these aims, MCC requests $150,000 per year in Developmental Funds, allowing
the center to achieve several key objectives outlined in the Strategic Plan, including fostering research that
aligns with its research priorities, expanding transdisciplinary opportunities for research teams, and increasing
clinical studies that are informed by MCC basic research. MCC will also continue partnerships with other major
research centers across campus, allowing cancer research to have an impact far beyond what MCC alone can
achieve, and will foster the maturity of a new process by which Community Advisory Board members directly
contribute to the CCSG pilot reviews, allowing community input to inform and influence funding decisions.

Public health relevance
Project Narrative Not applicable. This document is attached to satisfy electronic submission requirements.